Role of Radial Glial Tiling in the Formation and Malformation of the Cerebral Cortex

Regularly interspaced, non-overlapping, tiled organization of polarized radial glial cells (RGCs)
serves as an instructive framework to generate and organize neurons in the developing cerebral
cortex. Disruptions in this fundamental cellular feature of the developing cerebral cortex lead to
a spectrum of neurodevelopmental disorders (e.g., autism, schizophrenia, and epilepsy) and
brain malformations (e.g., lissencephaly, schizencephaly, microencephaly, and
macro/microgyria). However, little is known about the molecular logic of radial glial tiling and
how it drives the appropriate formation of the cerebral cortex. We discovered that RGC tiling is
dependent on Memo1 (Mediator of cell motility 1). Genetic mutations in MEMO1 lead to autism.
Memo1 thus provides a window into the mechanisms that instruct radial glial tiling and the
resultant assembly of the cerebral cortex. Leveraging the latest advances in progenitor specific
mouse genetic models of Memo1, MADM based profiling of radial glial differentiation, mapping
of Memo1 interactome, mechanistic dissection of cellular functions of Memo1, live imaging of
Memo1 deficient radial glial cell functions, and functional analysis of MEMO1 mutation from
autism probands, we aim to (a) discover the role of Memo1 in the tiling of RGCs and the
resultant formation of the cerebral cortex, (b) identify the Memo1 interactome that contributes to
and determines RGC tiling, and (c) interrogate the contributions of MEMO1 to cortical
malformations associated with autism. Collectively, the outcome of this work will reveal the
molecular logic underlying radial glial tiling, the vital relevance of this process for cortical
development, and how changes in this process can cause brain malformations and
neurodevelopmental disorders. Importantly, understanding how radial glial cells are assembled
and organized appropriately to facilitate cerebral cortical formation offers the opportunity to
redraw the rules of corticogenesis in the service of better diagnostic and therapeutic insights
into neurodevelopmental disorders.

Public health relevance
Tiled radial glial cells (RGCs) provide a template for the formation of the cerebral cortex and abnormalities in this intricate organization of RGCs lead to aberrant generation, placement and connectivity of neurons in human cerebral cortex. Using Memo1 (Mediator of cell motility 1), an autism linked gene, as a molecular guide, this research effort will decipher the blueprint underlying radial glial tiling. Understanding the molecular logic of radial glial tiling and the relevance of this process for cortical development and neurodevelopmental disorders will enable us to target and ameliorate brain malformations that lead to intractable brain diseases such as autism and epilepsy.